High-Energy Tunable Nanosecond-Pulsed Laser

The requested instrument is a high-energy broadly tunable nanosecond-pulsed laser
manufactured by Opotek LLC. This instrument will serve as an excitation source for a wide array
of nanosecond time-resolved transient spectroscopies (luminescence, UV-Visible absorption,
FTIR, resonance Raman) as well as an excitation source for steady-state Raman spectroscopy.
The laser will be housed in the Beckman Institute Laser Resource Center, a facility focused on
providing the Caltech research community with instrumentation and guidance in steady-state
and time-resolved laser spectroscopy, conventional spectroscopy, photophysics, and
photochemistry. A primary focus of the Center is time-resolved spectroscopy for measurements
of chemical and biochemical kinetics, and the elucidation of chemical reaction mechanisms. The
laser will furnish essential support for three NIH-funded research programs of Major Users, as
well as three externally funded and three internally funded research programs of Other Users.
The NIH-funded programs include: studies of radical transfer pathways in iron and copper
oxygenases and oxidases; elucidation of the photochemical mechanisms of copper-based
catalysts involved in (enantioselective) C–N bond formation; mechanistic investigations of
dinitrogen reduction chemistry catalyzed by bioinspired iron model complexes; and
investigations of DNA mediated charge transfer processes in Pseudomonas aeruginosa
biofilms. Other research projects utilizing the instrument will address: mechanistic investigations
of lytic polysaccharide monooxygenase catalysis; photophysical investigations of
arylisocyanide-metal complexes; development of table-top plasma sources for soft to hard x-
rays; time-resolved spectroscopic characterization of photoredox mechanisms; and time-
resolved spectroscopic characterization of bipentacene triplet states generated via singlet
fission.

Public health relevance
The requested laser instrumentation will be used to examine detailed mechanisms of fundamental chemical and biochemical processes. The chemical processes are critical for the synthesis of bioactive compounds for drug development. The biochemical processes are essential steps in biosynthetic and bioenergetic pathways critical for living cells.